In vitro screen for inhibitors of the inositol kinases ITPK1 and PPIP5K

The NCATS Early Translation Branch (ETB) hosts a broad and comprehensive program for the discovery of drug candidates directed towards rare diseases and pharmacological tools to probe the function of the human genome. ETB conducts research to understand the underlying principles driving the translation of basic research discoveries into tangible improvements in human health.

During this period, the collaborative team began optimization and miniaturization of high-throughput amenable assays to enable initial screening against these two inositol kinase targets.